Bioengineering of phage-derived particles as a discovery platform for muscle gene therapy

PROJECT SUMMARY
Gene therapy provides a functional cure for patients with genetic disorders and is particularly relevant to the
treatment of monogenic rare diseases (those caused by a single gene), such as Duchenne muscular dystrophy
(DMD). Adeno-associated virus (AAV) is the most prevalent and clinically successful viral gene therapy.
However, as a delivery platform, it exhibits significant limitations when it comes to immunogenicity, cargo ca-
pacity, manufacturability, and ease of cell type-specific targeting. Other platforms, such as lipid nanoparti-
cle/mRNA formulations, can be manufactured at scale but only induce untargeted and transient gene expres-
sion. Therefore, while each has its strengths and weaknesses, there is currently no platform available that
brings accessible and durable gene therapy to rare genetic disorders.
The goal of M13-Tx is to develop a next-generation in vivo gene delivery platform that addresses the current
key limitations of existing gene therapy technologies. This platform is based on phage-derived particles (PDPs)
– an immune-privileged, easily engineerable, and efficiently produced derivation of M13 bacteriophage – spe-
cifically designed for the transduction of human cells. By the combination of directed evolution and rational de-
sign, these PDPs can be engineered to target any tissue and deliver up to 20kb DNA cargo.
In this Phase I SBIR, M13-Tx proposes to engineer and screen PDPs to successfully deploy a cargo carrying
the functional copy of DMD gene coding for dystrophin protein in muscle tissue in vivo. In contrast to existing
AAVs, which can only pack a fraction of the DMD coding sequence, the PDPs will deploy the full DMD gene
only in muscle tissue for durable and redoseable treatment of Duchenne muscular dystrophy.
The final product of this proposal is lead PDPs, ready to be tested in the DMD mouse model. The lead PDPs
and muscle-specific deployment can be utilized across rare diseases caused by mutations of different genes
but manifested in the same tissue (e.g., Myotonic Dystrophy and Facioscapulohumeral Muscular Dystrophy).
Moreover, the same workflow can be used to find PDPs for other difficult-to-target tissues (e.g., lung and
CNS). The proposed study will serve as a proof-of-concept, showing that PDPs can be selected for specific
gene delivery purpose, given their engineerable coat and easily modified cargos. Developing this technology
will revolutionize gene therapy by presenting a versatile and affordable gene delivery platform.

Public health relevance
PROJECT NARRATIVE There is currently no affordable and redoseable gene therapy that can deliver a large DNA cargo to specific tissues and trigger durable correction of the underlying genetic problem while evading immune surveillance. M13-Tx proposes to engineer a next-generation in vivo gene delivery technology based on rational design, screening and in vivo selection of phage-derived particles (PDP), capable of delivering a full dystrophin gene to muscle cells for the treatment of Duchenne muscular dystrophy (DMD). Both the PDP delivery and deployment platform, and the workflow for selecting the best-performing in vivo variants, are generalizable across rare dis- eases.